TFEB and age-associated B cells in autoimmunity

Project summary
Age-associated B cells (ABCs) is a recently described B cell subset that accumulate during aging or
development of systemic autoimmunity. They contribute to dysregulation of humoral immunity during aging and
production of autoantibodies in autoimmune diseases. They are particularly responsive to TLR signaling and
can be generated in both T cell dependent and T cell independent manner. Its metabolic and transcriptional
regulation remain poorly understood. The MiTF/TFE transcription family member TFEB is a key modulator of
lysosomal biogenesis, autophagy and lipid metabolism. We present preliminary evidence suggesting a
potential contribution of TFEB transcription factor to the metabolic fitness of ABCs. TFEB overactivation leads
to abnormal mitophagy and impaired mitochondrial metabolism in B cells, and dampened humoral immunity
against T cell independent antigens. ABCs from aged mice, aged human donors and patients with systemic
lupus erythematosus (SLE) exhibit elevated TFEB expression and its associated transcriptional signature. Our
central hypothesis is that TFEB modulates systemic autoimmunity partly by controlling the
mitochondrial metabolism and function of ABCs. Specifically, increased TFEB activity will reduce
mitochondrial metabolism of ABCs, reduce autoantibody production and ameliorate SLE pathology, whereas
reduced TFEB activity will have the opposite effects. In Aim 1, we will perform metabolic assays,
transcriptomics and metabolomics to define the functions of TFEB in ABC generation, mitochondrial
metabolism and function using novel genetic gain-of-function, loss-of-function, and reporter models. In Aim 2,
we will test how TFEB may contribute to SLE pathogenesis using a TLR7 ligand induced lupus model on TFEB
gain-of-function and loss-of-function mouse models. Our research will establish the first metabolic metabolism
controlling ABCs.

Public health relevance
Project narrative A specific immune cell type, called “age-associated B cells”, contributes to the development of systemic autoimmunity. Cell metabolism controls immune cell activity. We aim to investigate how metabolism of age- associated B cells is modulated, which may provide clues on how to target immune cell metabolism to ameliorate autoimmune diseases, such as systemic lupus erythematosus.